Microscopy characterization of a novel tau model of Alzheimer's Disease in monkeys

PROJECT SUMMARY / ABSTRACT
Alzheimer’s Disease (AD) is a devastating condition that affects more than 6 million Americans, with a total
annual cost >$300 billion estimated in 2022. Currently, there are few treatments to counteract or slow the
progression of AD, with promising findings in mice generally failing to translate into successful therapies for
patients. Monkey models may provide a more powerful translational model. This work proposes to characterize
fully a monkey model of AD tau pathology by performing microscopic analyses on the brains of rhesus macaques
I am currently behaviorally testing to characterize tau-based cognitive decline (R24AG073138). Previous work
has targeted the highly vulnerable entorhinal cortex (ERC) for unilateral infusions of an adeno-associated virus
(AAV) expressing a double tau mutation known to cause tau-related dementia in humans (P301L/S320F) and
characterized neuropathology at 1.5, 3, and 6 months after viral infusion. This causes extensive and progressive
neuroinflammation and tau-based neuropathology, including neurofibrillary tangles, in ERC and in
hippocampal and neocortical targets of ERC. PET imaging in these monkeys displays robust tau expression.
Biomarkers for neurodegeneration are elevated in serum and CSF relative to baseline levels. The progressive
time course relative to the time of vector infusion is a great strength in terms of using this model for therapeutic
development. These early studies demonstrated the potential for this model to replicate pathological features of
AD in the monkey brain and to capture aspects of pathology that have not been well-modeled in rodents. The
successful characterization of this model with cutting-edge scientific methods will result in a multi-faceted and
highly validated rhesus monkey model of the tau-based degenerative phase of AD with unprecedented
translational power for efficiently developing and testing therapeutics throughout the pathological process. To
meet this critical need, this project pursues two Specific Aims: 1) This project performs comprehensive
microscopic studies to determine the regional and laminar patterns of tau-based neuropathology and extent of
neuronal loss within the ERC and hippocampus 12 months after AAV injection into ERC, as well as more distal
neocortical sites. This project correlates the tau-based pathology, including neuronal death, with the behavioral
data I am currently collecting from the same animals. 2) This project performs comprehensive microscopic
studies to determine the regional and laminar patterns of synaptic and neuronal health within the ERC and
hippocampus, as well as more distal neocortical sites. This project correlates synaptic and neuronal health, which
is closely related to neuronal functionality, with the tau-based pathology described in Aim 1, as well as the
behavioral data I am currently collecting. A particularly novel aspect of this project is the utilization of immediate
and early genes (IEGs) to study the health of neural circuits in use by the animal when exposed to a novel
environment immediately before perfusion. All microscopic analyses and behavioral correlations will be highly
quantitative and rigorous, facilitating therapeutic development and correlation across prior datasets.

Public health relevance
PROJECT NARRATIVE Alzheimer’s Disease (AD) is a devastating condition that affects more than 6 million Americans, with a total annual cost >$300 billion estimated in 2022. Currently, there are few treatments to counteract or slow the progression of AD, with promising findings in mice generally failing to translate into successful therapies for patients. I propose to fully characterize a novel monkey model of tau pathology in AD which, if successful, will provide a powerful translational model for effective development of therapies.